EXPANSION AND DISTRIBUTION OF NOVEL NGCMS

Under this SOW the goal is to fund a central core facility (HCMI contractor) to expand and quality up to 200 different HCMI cancer models during the Period of Performance (POP) of 36 months from existing Cancer Model Development Centers (CMDC’s) as well as from new model contributors. The NGCMs need to be available to the research community for use in any and all experiments and uses.